ICERCH-Supporting the HEAL Pain ERN

Vanderbilt University Medical Center is responding to RFA-TR-22-012 to be the Recruitment Resource Center (RRC). We will work collaboratively with each ERN study team and the other HEAL ERN Resource Centers and continue to develop and monitor comprehensive strategies to address barriers to recruitment and retention in the five funded HEAL pain studies and two additional studies, demonstrate their effectiveness in recruiting participants and broadly disseminate evidence on the most effective approaches to recruitment and retention of people experiencing pain. Our Recruitment Resource Center application has the following Specific Aims: Specific Aim 1. Develop comprehensive recruitment and retention strategies for HEAL Pain ERN clinical trials to ensure studies efficiently enroll and retain a sufficient number of participants who represent the affected pain population.
Specific Aim 2. Provide centralized participant-centered recruitment and retention services to support HEAL Pain ERN sites in identifying, approaching, screening, consenting, enrolling, and retaining participants.
Specific Aim 3. Implement, study, and refine novel recruitment and retention strategies (such as EHR-based participant screening, e-consent, embedding patients on study teams, and behavioral, informational and/or social incentives) and disseminate evidence on the most effective approaches to recruitment and retention of people who have pain. Our collaboration with ERN investigators and integration with the other TIN Resource Centers will maximize the likelihood of successful and timely completion of the HEAL Effectiveness Research Network clinical trials, leading to translation of research findings to the effective interventions and management strategies for pain while, improving functional outcomes, and reducing pain across the continuum of acute to chronic pain.

Public health relevance
ICERCH as the Recruitment Resource Center will work collaboratively with each ERN study team and the other HEAL ERN Resource Centers and continue to develop and monitor comprehensive strategies to address barriers to recruitment and retention in the five funded HEAL pain studies and two additional studies, demonstrate their effectiveness in recruiting participants and broadly disseminate evidence on the most effective approaches to recruitment and retention of people who have pain. The HEAL Pain Management Effectiveness Research Network (ERN) is a key component of the initiative and to be successful, these ERN trials will need to efficiently recruit participants and minimize dropouts. To ensure HEAL Pain ERN studies accrue and retain the number of participants required to assess primary and secondary outcomes, we propose a Recruitment Resource Center to support the development of a robust recruitment infrastructure, complete with the tools, resources, and innovative strategies needed to proactively address recruitment barriers and rapidly identify and mitigate emerging roadblocks across sites.